CANCER EDUCATION PROGRAM

This project is designed to improve the quality of Cancer Education at MCV at the undergraduate, graduate and continuing education levels. At the undergraduate level, activities will include assessment of cancer coverage within an organ system curriculum and development of additional offerings in cancer for both the preclinical and clinical years. At the graduate level, activities will include core instruction for house staff in the major residency programs and development of a clinical associate program for graduate physicians in surgical pathology (oncology), pediatric hematology oncology, surgical oncology, medical oncology and gynecologic oncology. At the continuing education level, activities will include the development of community hospital cancer teams and need based continuing education courses in oncology. Evaluation will focus on both individual program elements and overall project impact.